INSULIN RESISTANCE AND LIPID ABNORMALITIES

The purpose of this study is investigate why immigrant south asian are at higher risk for developing diabetes and coronary artery disease compared to caucasians living in the United states.